Economic security policy and birth outcomes among socio-economically disadvantaged women

Project Summary
A growing body of work has demonstrated that increases in the generosity of cash and in-kind benefits
received by low-income women from economic security policies (ESPs) are associated with improved birth
outcomes, particularly low birth weight (LBW) (less than 5 pounds, 8 ounces) and preterm birth (PTB) (before
37 weeks). Because single ESPs rarely fill all economic gaps, most low-income families do not use ESPs in
isolation, but rather “package” them to make ends meet. While the effects of Supplemental Nutrition Assistance
Program, the Earned Income Tax Credit, and the minimum wage have been studied extensively, there have
been few studies of Unemployment Insurance and no identified studies of the combined effects of these four
ESPs. This study builds on existing research that demonstrates positive overall effects of individual ESP
generosity on birth outcomes among the low-income population and differential effects based on social
statuses. The study also draws from research showing that more generous ESPs improve correlates of
maternal-fetal health. Using the Panel Study of Income Dynamics, a nationally representative, longitudinal data
set, this study will examine how individual ESPs and ESP combinations compare to one another in terms of the
size of their effects on LBW and PTB. Additionally, this study will be the first to determine the relative
contribution of four potential mediators explaining the link between ESP generosity and birth outcomes (i.e.,
healthcare access, food insecurity, psychological distress, and prenatal health behaviors). Lastly, this study will
identify whether the effects of ESP generosity is moderated by poverty level, race, marital status, and
education. As the US social safety net has shifted to one that rewards labor market participation, ESPs have
become a more familiar feature of working poor households. These households—low-income, but working—
account for the majority of poverty in the US and their ranks are likely to grow in the wake of the Great
Recession and the COVID-19 pandemic. This suggests a pressing need for information on which policies
generate the greatest returns, how they influence birth outcomes, and for whom they are most effective. As
such, this research will contribute significantly to scientific and policy efforts to reduce rates of LBW and PTB
among low-income women and reduce inequalities in birth outcomes.

Public health relevance
Project Narrative Comparing the US to 184 other nations, only 40 nations have higher rates of low birth weight (LBW) (less than 5 pounds, 8 ounces) and 53 have higher rates of preterm birth (PTB) (before 37 weeks). The surprisingly high incidence of LBW and PTB is driven primarily by birth outcomes among low-income, disproportionately Black, mothers, pointing to social and economic determinants of health. This study uses the Panel Study of Income Dynamics, a nationally representative, longitudinal dataset to: (1) compare the effects on birth outcomes of individual ESPs and ESP combinations; (2) determine the extent to which improvements to healthcare access, food insecurity, psychological distress, and prenatal health behaviors mediate the relationship between ESP generosity and birth outcomes; and (3) identify whether ESP generosity effects are moderated by poverty level, race, marital status, and/or education. By improving scientific knowledge of which ESPs or ESP packages work best in general, for specific health risk-factors, and for specific groups, this research will support the funding, design, and delivery of policies and interventions that promote economic security and reduce rates of, and inequalities in, LBW and PTB.